Administrative Core

Project Summary
The Minnesota Tissue Mapping Center (MN TMC) for Senescent Cells (SnC) Administrative Core (AC) will be
led by two PIs with synergistic expertise: Dr. Laura Niedernhofer, an expert in cellular senescence who
participated in the numerous NIH Think Tanks that led to this Common Fund U54 RFA, and Dr. Constantin
Aliferis, Director of the UMN Institute for Health Informatics (IHI) and Chief Research Informatics Officer. The
main goals of the AC are to facilitate the interaction of all of the MN TMC cores to maximize the TMCs
productivity and to create a seamless interface between the MN TMC and other TMCs, the Consortium
Organization and Data Coordinating Center (CODCC), and the technology grant (UG3/UH3) awardees to
maximize the synergy and productivity of the SenNet Consortium. The specific responsibilities of the AC are
to: i) coordinate and provide oversight for the activities of the MN TMC Cores to facilitate access to human
tissues, subject clinical data, tissue analysis, data analysis, and data integration; ii) administer a pilot project
program focused on developing innovative approaches to identify and characterize SnCs; iii) coordinate MN
TMC activities with those of the other TMCs, including working with our Data Analysis Core (DAC) and the
CODCC to create standard operating procedures (SOPs) for data management and dissemination; and iv) work
with the DAC to ensure delivery of the data generated by our TMC to the CODCC in a timely fashion and in
compliance with the SenNet standard operating procedures and Common Data Elements set by the SenNet
Steering Committee.
The goals of the AC will be achieved through the following aims: 1) Oversee and coordinate efforts of the MN
TMC to ensure that research goals and milestones are met with highest quality standards; 2) Integrate input from
the MN TMC DAC and the SenNet CODCC to develop and ensure compliance with SOPs for generating data
sets that enable the development of a multi-dimensional atlas of SnCs with healthy human aging. 3) Oversee
and coordinate the exploration and evaluation of novel approaches for detecting, deeply phenotyping, tracing,
and selectively eliminating senescent cells as technologies emerge from pilot projects, Technology Development
Projects (UG3/UH3), other TMCs, and other relevant groups studying senescence or building cell atlases; and
4
) Coordinate the activities of MN TMC with other TMCs to optimize research efficiency and economies of scale
and scope, including contributing to the adoption and/or further development of data standards, analytic tools,
data sharing/visualization/discovery tools, and multi-site studies and training activities. Successful execution of
these aims will optimize the operations of MN TMC, maximize our contribution to SenNet, ensure SOPs that
enhance the rigor and reproducibility of the data collected on SnCs, and ensure compliance of our TMC with the
Standard Practices established by SenNet.